Project 1 - Toxicity and Liver Carcinogenicity of 1,4-Dioxane: Single Chemical and Mixtures Studies

PROJECT SUMMARY
1,4-Dioxane (1,4-DX) is an emerging drinking water contaminant. The potential for 1,4-DX exposure is
elevated for people living near Superfund or other types of 1,4-DX release sites. The International Agency for
Research on Cancer has classified 1,4-DX as a group 2B carcinogen with the primary organ target being the
liver in animal studies. Despite this concern, safety standards for 1,4-DX in drinking water have been slow to
develop and vary widely, with the variability being related to the uncertainty associated with its liver
carcinogenic potential. Mechanistic studies are urgently needed to (i) understand how 1,4-DX may contribute
to liver carcinogenesis by itself or in combination with other co-occurring drinking water contaminants [such as
trichloroethylene (TCE) and 1,1-dichloroethane (1,1-DCA)], (ii) determine the exposure concentration range
over which these effects occur, and (iii) identify potentially more vulnerable subgroups. Our preliminary studies
in mice have revealed molecular targets and pathways potentially involved in 1,4-DX carcinogenicity and set
the stage for the proposed studies. These preliminary studies utilized various 1,4-DX concentrations (50, 500
and 5,000 ppm) in drinking water for periods of up to 3 month. These studies revealed mild liver cytotoxicity
that is consistent with previous studies. The highest 1,4-DX dose induced assorted molecular changes in the
liver including: (i) persistent induction of NRF2 and its target proteins involved in anti-oxidative response (i.e.,
GCLC, GCLM, HMOX1 and NQO1), (ii) time-dependent induction of CYP2E1 (key oxidative pathway capable
of activating endogenous and xenobiotic compounds and a generator of reactive oxygen species), (iii)
centrilobular accumulation of the lipid peroxidation by-product 4-HNE, and (iv) elevations in the DNA damage
marker γH2AX. Importantly, these 1,4-DX-elicited molecular changes were amplified in a mouse model of
systemic glutathione (GSH) deficiency. This project will build upon these intriguing findings and investigate our
novel hypothesis predicting that long-term exposure to 1,4-DX causes liver tumorigenesis by disrupting redox
homeostasis, thereby potentiating genetic instability. This proposed 1,4-DX mode of action would be of high
relevance in assessing carcinogenic effects of co-occurring contaminants that may utilize or modulate
overlapping molecular pathways. We propose to (1) delineate the contribution of key redox pathways to 1,4-DX
liver carcinogenicity in vivo using transgenic redox mouse models, (2) identify the biological network motifs that
predict 1,4-DX-induced liver carcinogenesis and the dose response pattern for perturbation of these networks
in vivo, and (3) elucidate the capacity of co-occurring contaminants (TCE and 1,1-DCA) to modify 1,4-DX
carcinogenicity in human hepatocyte cells and zebrafish model systems.

Public health relevance
PROJECT NARRATIVE The goals of this project are to identify molecular mechanisms involved in 1,4-dioxane (1,4-DX) liver carcinogenicity and to assess the capacity of co-occurring contaminants (TCE and 1,1-DCA) in modifying 1,4- DX carcinogenicity. We propose to examine the mechanistic roles of key redox pathways and biological network motifs in 1,4-DX-induced liver carcinogenesis and elucidate the carcinogenic potential of co-occurring contaminant mixtures. This research will establish the dose response for key perturbations that are associated with 1,4-DX liver carcinogenicity and reveal whether unique susceptibility factors may predispose to a greater risk of liver carcinogenesis.